UCSF Nutrition Obesity Research Center

UCSF NORC Overview: Summary
The UCSF NORC integrates multiple research programs across several different areas of nutrition, obesity and
metabolism. Over the last twelve years, UCSF has actively expanded its research base in these critical subject
areas, and for the last four years, the NORC has greatly aided the recent phases of this expansion.
Specifically, this robust research base has benefitted from an administrative and facilities infrastructure
reflecting the diversity of the departments and centers pushing to expand NORC-relevant research at UCSF.
Renewal of the NORC will sustain this cohesive programmatic, administrative and shared facilities
infrastructure in order to further integrate the already strong research conducted at UCSF, providing a
framework for its coordinated future growth.
The UCSF NORC includes cellular, animal, translational, clinical, epidemiological, and behavioral research
directions. Despite this breadth, these programs are highly interactive with extensive collaborations amongst
even the most divergent of programs. For example, radiologists collaborate with clinical scientists to non-
invasively visualize metabolism in humans. Human geneticists collaborate with cellular and animal researchers
to investigate hypotheses more tractable in those systems. Behavioral scientists coordinate with nutritionists to
search for ways to improve outcomes. In all, the 58 interdisciplinary investigators within the UCSF-NORC
consist of a mixture of senior and early stage investigators with a collective 78 NIH grants relevant to obesity,
metabolism and nutrition research. Their collective goal is to define the underlying mechanisms of disease and
to significantly contribute to the prevention and treatment of obesity and its complications.
The purpose of the UCSF-NORC is to promote and grow research in obesity, nutrition, and metabolism at
UCSF and throughout northern California. This is realized by:
· Maintaining, improving, and promoting the interactions and collaborations of researchers in the field with
each other and with those outside the field.
· Supporting the maintenance and evolution of state-of-the-art Research Cores to meet the needs of obesity,
nutrition, and metabolism research.
· Facilitating the development of new research directions and the entry of new researchers into the field via
Pilot & Feasibility opportunities.
· Enriching the NORC research community through pertinent educational forums and other venues that
support the development and maintenance of research interactions.
· Integrating administrative support to ensure that the infrastructure meets the needs of the local obesity,
nutrition and metabolism research community.

Public health relevance
UCSF NORC Overview: Narrative The UCSF-Nutrition and Obesity Research Center (UCSF-NORC) is a highly integrated community of researchers spanning the spectrum from basic research through clinical implementation of new treatments. To achieve this, the NORC supplies, coordinates and oversees facilities and programs that bring these researchers together. Since its implementation four years ago, the NORC has increased the cohesiveness, and enhanced the visibility of nutrition, obesity and metabolism research at UCSF, thereby enabling the development of outstanding, cutting-edge and highly multi-disciplinary studies.